Communication and Dissemination Core

Project Summary
The Communication and Dissemination Core (Core C) shares and publicizes information about CDHA activities
and resources via multiple platforms and to varied academic, policy, and public audiences. In addition to
developing and maintaining CDHA’s web site as an information resource for CDHA affiliates, other researchers,
and the public at large, Core C staff also produce and manage a set of quarterly newsletters, weekly digests,
and social media accounts (Twitter/X, Bluesky, LinkedIn) promoting CDHA events, highlighting emerging
research in the demography of health and aging, celebrating affiliate achievements, and publicizing opportunities
for funding and collaboration. Core C staff also manages publicity and communication around CDHA regular and
special events, and tracks and documents CDHA affiliates’ compliance with NIH data management and sharing
policy. Finally, as the landscape of research and mass communication continues to change, CDHA will
experiment with new platforms and innovations in communications as they emerge, allowing us to continue
engaging effectively with our affiliates and broader publics.

Public health relevance
Project Narrative Per funding announcement instructions, the narrative is in the Overall section of this proposal.